Coordinating Center for Research Centers for Improving Management of Symptoms During and Following Cancer Treatment

Project Summary
To advance the Beau Biden Cancer MoonshotSM Initiative to accelerate cancer research and the Blue Ribbon
Panel’s recommendation to minimize cancer treatment’s debilitating side effects, RTI International will continue
to serve as the Coordinating Center (CC) for the Research Centers (RCs) for Improving Management of
Symptoms Across Cancer Treatments (IMPACT) Consortium. As the CC, RTI will provide leadership, scientific
expertise, and logistical support to the consortium projects that seek to improve symptom management across
the cancer treatment continuum (i.e., treatment with curative intent, treatment with noncurative/palliative intent,
cancer survivorship) and address the unique challenges of minority and medically underserved populations.
Specifically, we will enhance research efficiency, productivity, and impact by facilitating collaboration and
providing the logistical, communications, and operational support necessary to run a multicenter research
Consortium; facilitate the development of evidence-based symptom management recommendations based on
results across studies and research sites; and accelerate adoption of integrated systems for monitoring and
managing patient-reported symptoms by collaborating with RCs to broadly disseminate findings. This
application has specific strengths that will enhance the scientific productivity of the Consortium. The CC will
foster collaboration within the IMPACT Consortium by uniting diverse researchers around shared goals and
harmonized studies. RTI will promote effective communication by developing and maintaining custom web-
based tools for communications and document sharing. RTI will leverage data standards and harmonization
across the Consortium to catalyze data sharing and aggregation.

Public health relevance
Project Narrative Millions of cancer patients across the cancer care continuum suffer from complications associated with their illness, including high symptom burden and poor quality of life. RTI International’s Coordinating Center proposes to continue support of the Improving Management of Symptoms Across Cancer Treatments (IMPACT) Consortium by providing expert leadership, logistical support, and data coordination to the projects implementing methods to improve symptom management across the cancer treatment continuum and address the unique challenges of minority and medically underserved populations.